Nitric Oxide Regulation of Inflammatory Responses and Gene Expression

Human phagocytes, in particular neutrophils, were demonstrated to lack the capacity to endogenously produce NO under a number of ex vivo and in vivo conditions (J Immunol, 1994). Therefore, the ability of these cells to be regulated in a paracrine manner by exogenous sources of NO such as the endothelium has been explored.[unreadable] [unreadable] In addition to upregulating TNFalpha production (J Immunol, 1994), NO was found to modulate IL-8 mRNA levels and IL-8 production in human neutrophil preparations (J Infect Dis, 1998).[unreadable] [unreadable] We have confirmed that endogenously produced NO also up-regulates TNFalpha production using human U937 cells, a monoblastoid cell line, transfected to express murine iNOS (Blood, 1997).[unreadable] [unreadable] Investigation of TNFalpha regulation by NO resulted in the description of a cGMP-independent signaling pathway that utilizes cAMP downregulation as a signal transduction event (J Biol Chem, 1997).[unreadable] [unreadable] A NO-responsive Sp1 binding site was identified in the proximal TNFalpha promoter (J Biol Chem, 1999). NO-mediated decreases in cAMP leads to reduced Sp1 binding to the TNFalpha promoter with subsequent increases in TNFalpha transcription.[unreadable] [unreadable] Recent work has shown that NO downregulates the eNOS promoter through effects on Sp1 identical to those that cause alpha upregulation (J Biol Chem, 2003). For TNFalpha, an AP1 site upstream to Sp1 serves to reverse the direction of the NO response. Mutation of the AP1 site converts the effect of NO in TNFalpha from up to down regulation (eNOS-like).[unreadable] [unreadable] The IL-8 promoter lacks a canonical Sp1 site. Unlike TNFalpha, IL-8 regulation by NO both cGMP and cAMP-independent. Further, NO-p38 MAPK-dependent effect on protein binding to regulation of IL-8 has been found to be post-transcriptional and mediated via AU-rich elements in its mRNA 3 UTR (J Leuk Biol, 2004).[unreadable] [unreadable] An oligonucleotide microarray analysis in differentiated U937 cells has identified more than 100 additional NO regulated genes (BMC Genomics, 2006). NO was found to coordinate a highly integrated program of cell cycle arrest that regulated a large number of genes, but did not require signaling through cGMP. Therefore, in humans the antiproliferative effects of NO rely substantially on cGMP-independent mechanisms. Stress kinase signaling and alterations in mRNA stability appear to be major pathways by which NO regulates the transcriptome.[unreadable] [unreadable] Next, transcript stabilization by NO was investigated in human THP-1 cells using microarrays (Nucleic Acids Research, 2006). After LPS pre-stimulation, cells were treated with actinomycin D and then exposed to NO without or with the p38 MAPK inhibitor SB202190 (SB). Decay of 220 mRNAs was affected. NO was shown to stabilize transcripts while suppressing their translation through DICE-like, CU-rich elements (CURE) in target transcripts. NO activation of Erk1/2 was required, as was an associated increase in the binding of hnRNP proteins to mRNA. This work demonstrated a novel mechanism of NO-mediated posttranscriptional regulation.[unreadable] [unreadable] In our previous study (BMC Genomic, 2005), NO was shown to down-regulate Polo-like kinase 1 (PLK1), an evolutionarily conserved serine/threonine kinase essential for cell mitosis, and up-regulate p21/Waf1, a master cell cycle regulator critical for cell cycle progression. Both of these effects were independent of cGMP. Further investigation of this mechanism demonstrated that a NO-p38 MAPK-p21/Waf1 signal transduction pathway repressed PLK1 through a canonical CDE/CHR promoter element (J Biol Chem, 2007).[unreadable] [unreadable] Both NO and peroxisome proliferator-activated receptors (PPARs) protect the endothelium and regulate its function. Therefore, we tested for crosstalk between these signaling pathways using human umbilical vein and hybrid EA.hy926 endothelial cells (FASEB J, 2007). PPARalpha was activated by NO through a p38 MAPK dependent signal transduction pathway. This crosstalk mechanism may contribute to the anti-inflammatory and cytoprotective effects of NO in the vasculature and suggests new strategies for preventing and treating vascular dysfunction (see the Endothelial Dysfunction and Vascular Inflammation project for the proposed course of this work).